Administrative Core

Core A – Administration – Abstract
The Administrative Team will provide support in three principal areas: 1) administrative, fiscal and scientific
oversight; 2) coordination and communication about the Center to maximize its interaction with and impact on
external research, engagement, and translation; 3) evaluation of the Center to provide ongoing feedback and
quality improvement with respect to all its goals, including the Plan to Enhance Diverse Perspectives. Because
of the inherent complexity of research and engagement around microplastics (MPs) and human health, we have
carefully structured an Administrative team and structures to coordinate between two institutions (the University of
Rochester and the Rochester Institute of Technology), multidisciplinary researchers, the central role of the Materials
and Metrology Core (MMC), and engagement with diverse partners. Our internal coordination will be facilitated by
an Internal Steering Committee which will meet monthly, along with quarterly “All Hands” meetings to encourage
interaction among all members of the Center, including trainees, staff, and faculty, and monthly meetings of the
Microplastics Research Workgroup of Western New York. The Administrative Team supports multi-directional
interactions with external stakeholders by facilitating the Lake Ontario MicroPlastics Engagement and Research
(LOMPER) group, comprised of organizations with significant roles in management, policy, or public decisions
related to MPs. Core A also manages communications with and annual meetings of our External Advisory
Committee, co-hosting an annual Regional Microplastics Research Workshop, and facilitating presentations about
Center research with diverse academic audiences. The Administrative Team has dedicated effort to comprehensive
formative evaluation and feedback on all aspects of the Center. In addition to standard measures of research
progress success, such as publications and presentations, we will monitor use of the MMC, document non-
scholarly products (e.g. news media, CEC materials, science briefs), engagement of Center members in CEC
activities, and progress in implementing our Plan to Enhance Diverse Perspectives. Findings will be reporting on
a regular basis to the Internal Steering Committee, LOMPER, and External Advisory Committees to inform future
activities.

Public health relevance
Core A – Administration – Project Narrative The inherent complexity of microplastics (MP) and human health requires coordination, evaluation, adaptation, and facilitation of multidirectional communication both internally and externally. The Administrative Team will support these efforts through: 1) administrative, fiscal and scientific oversight; 2) communication about the Center to maximize its research, engagement, and translation impacts; 3) evaluation activities that provide ongoing feedback on Center goals, including the Plan to Enhance Diverse Perspectives. Our intentionally collaborative administrative structures will support convergent multidisciplinary, engaged, systems science that informs effective solutions.